Chromatin architecture disruption and the vicious cycle of aging.

PROJECT SUMMARY
Changes in nuclear/chromatin architecture are a hallmark of aging. Disruption of the nuclear lamina and
associated heterochromatin are commonly observed in various aging contexts, including premature aging
diseases, cellular senescence, and normative aging. These structural changes were proposed to trigger the
transcriptional derepression of at least two subsets of genes: LINE-1 (L1) and genes lacking CpG islands (CGI-
genes). Increased transcription of L1, the only active retrotransposable elements (RTEs) in humans, and the
failure of its surveillance mechanism result in cytosolic RTE cDNA formation via reverse transcription that causes
chronic sterile inflammation in aged tissues. In parallel, we have shown that heterochromatin decondensation
in aged cells causes uncontrolled expression of CGI- genes, which generally associate with heterochromatin in
normal conditions (misexpression of CGI- genes). Aberrant activation of CGI- genes drives various age-
associated degenerative changes, including previously established hallmarks of aging, ranging from cellular loss
of functional identity and increased transcriptional noise, age-associated secretory phenotypes to chronic
inflammation. These prior observations propose that chromatin architecture disorganization and the resulting
L1 and CGI- gene activation play as a master instigator of multivariate hallmarks of aging. Our preliminary
analysis suggests that this relationship is not unidirectional; L1 activation and CGI- gene misexpression would
mutually activate each other and, furthermore, facilitate chromatin architecture disruption. This proposed study
will test the novel hypothesis that the mutual activations among RTE/CGI- genes/nuclear architecture form a
“vicious cycle” intensifying physiological deterioration during aging. In Aim 1, We will validate the mutual
activation effects between chromatin architecture disruption and RTE activation during normative aging. Aim 2
will test the hypothesis that age-associated L1 activation facilitates physiological deterioration by triggering CGI-
gene misexpression. In Aim 3, we will test the hypothesis that the secretome of aged cells with disrupted
chromatin architectures can locally/systemically propagate nuclear architecture disruption and L1 activation.

Public health relevance
PROJECT NARRATIVE Changes in nuclear/chromatin architecture are a hallmark of aging. Understanding the underlying mechanism will guide us to advanced therapeutic strategies for aging and associated diseases. This proposed study will test the novel hypothesis that the mutual activations among chromatin architecture, retrotransposable elements, and genes lacking CpG islands form a “vicious cycle” intensifying physiological deterioration during aging.